SAFETY AND EFFICACY OF VOGLIBOSE IN NIDDM

To evaluate the safety and efficacy of 0.1, 0.5, 1.2, and 5mg t.i.d. of voglibose when administered orally, to 666 NIDDM patients for 26 weeks as compared to matching placebo, following a placebo-controlled eight week Lead-in Period.